The 6th Biennial Science of Global Prostate Cancer Disparities in Black Men of African Ancestry

PROJECT SUMMARY In 2010, the Prostate Cancer Transatlantic Consortium (CaPTC) organized the inaugural Science of Global Prostate Cancer Disparities (SGCaPD) in Black Men’s Conference to provide a platform for addressing the complexity of prostate cancer (CaP) disparity in Black men. Since the inaugural conference in 2010, the SGCaPD conference has fostered a unique approach to understand and address CaP disparities in Black men. With the support of the NCI, the previous biennial SGCaPD conferences have resulted in several scholarly achievements, including: (1) proceedings publications; (2) a global CaP special issue in ecancermedicalscience; (3) multi- institutional grant collaborations; (4) multi-institutional, trans-disciplinary prostate health disparity projects; (5) global CaP advocacy initiatives; (6) research guidelines; and (7) a standardized global CaPTC-AC3 Behavioral and Epidemiological (CABE) data elements and measures that are culturally appropriate for studying CaP in Black men globally. To continue to meet our long-term goal of eliminating the CaP disparities experienced by Black men, we are proposing the sixth Biennial SGCaPD Conference. For the first time, the conference will be held in Europe and will focus on fostering research skills and sharing research results that develop and test the feasibility of CaP-relevant interventions in Blacks or determines the biological basis for CaP disparities in Blacks. This application plans to foster research collaborations among 20 Early Stage Investigators (ESIs) from North America, Europe, Africa and the Caribbean for global CaP research collaborations in one of four areas: (1) Genomics; (2) Bioinformatics/Data Science; (3) Behavioral Research; and (4) Clinical Research.

Public health relevance
PROJECT NARRATIVE The 6th Biennial conference on “The Science of Global Prostate Cancer Disparities in Black Men” is proposed to foster research skills and share research results that develop and test the feasibility of prostate cancer-relevant interventions in Blacks or determines the biological basis for prostate cancer disparities in Blacks.